Mechanism of Acquired Resistance to VEGF-R Antagonists in RCC

DESCRIPTION (provided by applicant): One of the key advances in the field of renal ell cancer (RCC) is the development and approval of the tyrosine kinase inhibitors (TKIs), sorafenib and sunitinib. While these inhibitors of vascular endothelial growth factor (VEGF) driven angiogenesis have impressive clinical activity, the response to these agents is finite with resistance developing within 5-12 months. Development of resistance to such agents possibly with accompanying disease acceleration might negate much of the potential value of the therapy. We have found, in a mouse model of RCC, that resistance to sorafenib and sunitinib therapy is accompanied by a loss in interferon gamma (IFNg) signaling and that resistance occurs in the setting of renewed angiogenesis as seen by Arterial Spin Labeling Magnetic Resonance Imaging. In addition, we have found evidence that resistance to VEGFR TKI therapy is reversible as resistant tumors respond to therapy again when they are reimplanted into naive hosts. Our proposal outlines the study of the role of IFNg in resistance to VEGFR TKIs to further understand the biology of resistance. Our hypothesis is that loss of IFNg signaling is sufficient to lead to resistance and that restoration of one or more of the IFNg regulated chemokines may prevent or delay resistance to treatment with sorafenib or sunitinib. Advances in the understanding of these mechanisms of resistance could greatly enhance the therapeutic options for patients with metastatic RCC.

Public health relevance
PUBLIC HEALTH RELEVANCE: Renal cell carcinoma (RCC) exhibits a period of disease stabilization in response to inhibitors of vascular endothelial growth factor receptor (VEGFR). However, this response is inevitably ensued by the development of resistance to therapy. We have identified a loss in interferon gamma signaling at the time of resistance to VEGFR inhibitors. This proposal seeks to confirm this finding and extend it to develop new treatments for RCC. PROJECT NARRATIVE: Renal cell carcinoma (RCC) exhibits a period of disease stabilization in response to inhibitors of vascular endothelial growth factor receptor (VEGFR). However, this response is inevitably ensued by the development of resistance to therapy. We have identified a loss in interferon gamma signaling at the time of resistance to VEGFR inhibitors. This proposal seeks to confirm this finding and extend it to develop new treatments for RCC. __SpecificAimsTextDelimiter__ 10. STATEMENT OF HYPOTHESIS AND SPECIFIC AIMS Several agents targeting the vascular endothelial growth factor receptor (VEGFR) in renal cell carcinoma (RCC) have demonstrated significant single-agent efficacy. Two such agents, the multi-targeted tyrosine kinase inhibitors (TKI) sorafenib and sunitinib, have recently gained FDA approval for treatment of patients with metastatic RCC. Although these agents show significant clinical activity, they produce few if any complete or durable responses. Tumors develop resistance to VEGFR inhibition at a median of 5-11 months, at which point tumor growth resumes, sometimes at an accelerated pace, even with continued TKI administration. The biological basis for this acquired resistance to antiangiogenic therapy is largely unknown. Several potential mechanisms might be involved. Resistance could occur via a stable mutation developing in a drug target on the tumor cell, as has been reported in the lung cancer during resistance to EGFR inhibitors, or CML during resistance to imatinib. Alternatively, resistance may occur through the restoration of angiogenesis and blood flow within the tumor. At the biological level this could occur via activation of alternative (non-VEGFR dependent) compensatory pathways of angiogenesis, the inhibition of angiostatic pathways or by renewed signaling through an incompletely inhibited VEGF receptor. We have developed a mouse model of RCC resistance to sorafenib and sunitinib in which treatment of xenografts leads to stabilization or reduction of tumor size for a brief period of time, followed by resumption of tumor growth despite continued treatment. This model has allowed us to establish that resistance is associated with restored angiogenesis, "angiogenic escape", and that it appears to be reversible. Additionally, we have identified, at the molecular level, several mechanisms that potentially contribute to the restored angiogenesis; specifically the down-regulation of the interferon gamma (IFNg) pathway. This proposal will confirm and further elucidate these findings and investigate potential mechanisms to overcome resistance. Hypothesis: Our hypothesis is that resistance to VEGFR inhibition occurs by renewed angiogenesis resulting in part from down-modulation of IFNg signaling. Specific Aim 1: Identify the mechanism of loss of IFNgR expression In efforts to find a means by which to prevent the loss of IFNgR, we will consider several potential mechanisms by which IFNgR may be down-modulated. In an in vitro system, we will explore the role of receptor endocytosis/lysosomal degradation in IFNgR regulation and study the role of the proteasome in IFNgR down- modulation. The goal of this Aim is to identify possible strategies to prevent IFNgR loss. Specific Aim 2: Determine the effect of IFNgR down-modulation on chemokine loss and TKI resistance We hypothesize that loss of IFNgR expression leads to chemokine loss and contributes to resistance, thus we will decrease IFNgR expression using shRNA technology. As we do not yet know the mechanism of IFNgR loss, and we can not yet prevent this event, we will determine the effect of IFNgR down-modulation on chemokine production in vitro and assess the effect of IFNgR down-modulation on tumor growth in vivo. Specific Aim 3: Assess the sufficiency of IFNg-regulated chemokine supplementation to combat TKI resistance We postulate that chemokine loss leads to continued angiogenesis despite VEGFR blockade. Thus, we will introduce chemokines to sunitinib-and sorafenib-resistant tumors and determine the effect of chemokine supplementation on tumor growth alone, and in combination with VEGFR TKIs. Tumor growth in these experiments will be assessed by radiographic and histologic parameters. Successful completion of the Specific Aims will not only elucidate the role of IFNg signaling in resistance to VEGFR TKIs but also pave the way for therapeutic interventions that could prolong the period of responsiveness to these agents in patients with metastatic RCC.